A novel system used by pre-implantation mammalian embryos to amplify environmentally-induced changes in sperm miRNA content after fertilization.

Summary
Transgenerational epigenetic inheritance involves transmission of the effects of experiences to offspring
across generations via epigenetic changes in germ cells. It is well established in lower organisms like C. elegans
and plants, and growing evidence implies a similar phenomenon occurs in mammals including humans. Much
support for this process in rodents derives from experiments on male mice exposed to chronic psychological
stress, where stress-type specific changes in the levels of specific sperm miRNAs have been implicated in
transmitting stress-associated traits across generations. However, sperm contain much lower levels of miRNAs
than those of most cells, including those in early embryos. This fact implies a system must exist in embryos to
magnify and extend environmental changes in their sperm content after fertilization. In fact, an auto-amplification
systems exists and is necessary for transgenerational epigenetic inheritance in lower organisms. However, an
analogous system has not been reported in mammals. This grant is driven by our recent discovery of what
appears to be a novel amplification system for the sperm miR-34/449 family. These mRNAs are of particular
interest in this context because we implicated them in the paternal transmission of enhanced anxiety and
defective sociability displayed specifically to female offspring of male mice exposed to Chronic Social Instability
(CSI) stress. We found that CSI stress reduces levels of miR-34b/c and miR-449a/b not only in sperm of male
mice exposed to CSI stress but also in early embryos derived from them through at least the blastocyst stage of
early embryogenesis, even though the levels of these miRNAs in sperm are much lower than that normally
present in preimplantation embryos. The amplification system we uncovered is based on our findings that miR-
34c normally positively regulates the expression of its own gene and that for miR-449 in preimplantation mouse
embryos, and that this system appears to be suppressed in embryos from CSI stressed males. Surprisingly, we
do not detect changes in the primary transcripts or partially processed forms of miR-34c in these embryos,
suggesting sperm miR-34, and possibly miR-449, regulates the stability of embryo produced members of this
miRNA family. The potential relevance of this system to humans is supported by our findings that; a) both miR-
34 and miR-449 levels are also reduced in sperm of men who experienced severe abusive and/or dysfunctional
family life when young; and b) a similar amplification system appears to exist in human embryonic stem cells.
The goal of this proposal is to test this hypothesis by measuring the half-lives of miR-34 and miR-449 and their
extent of their “tailing” and “trimming”, which are part of the degradation process. We anticipate that these
findings will justify more long-term funding for experiments that reveal the how these miRNAs control their own
degradation, since this process may necessary for specific forms of transgenerational epigenetic inheritance in
both mice and men.

Public health relevance
A growing body of evidence in both animal models and humans supports the idea that the effects of one’s experiences can be transmitted to offspring through the process of epigenetic inheritance induced by environmental changes in the content of sperm miRNAs that are thought to influence embryo development after fertilization. However, sperm miRNA levels appear to be too low for their changes by the environment to significantly affect embryos. This proposal will advance our understanding of a potential resolution to this dilemma based on our discovery of a novel system in early embryos that can potentially amplify environment- induced changes in sperm miR-34c content after fertilization.